Subplate-dependent mechanisms of cortical circuit assembly

PROJECT SUMMARY/ABSTRACT
Cerebral cortex function requires correct assembly of circuit connectivities during development. Subplate
neurons, strategically positioned at the gray and white matter interface, play essential roles in assembling cortical
circuits, notably in guidance of thalamocortical axons and formation of sensory maps. Subplate neurons have
also been implicated in corpus callosum formation. Three non-cell autonomous mechanisms by which subplate
neurons support axon pathfinding have been proposed: 1) pioneering, wherein subplate neurons extend the first
axons and lay a path for cortical axons to follow; 2) co-fasciculation, wherein subplate descending axons closely
interact (“handshake”) with ascending axons to guide reciprocal connectivity; 3) extracellular matrix, wherein
subplate neurons provide a substrate for axon growth in nascent white matter. Subplate ablation studies have
shown subplate neurons to be indispensable. However, the genetic underpinnings of subplate neuron-mediated
axon guidance are largely unknown, in part due to a lack of genetic access to subplate neurons at embryonic
stages of circuit development. In a recent study (Doyle et al., PNAS, 2021), we reported a strategy to genetically
target subplate neurons. Using this approach to interrogate gene necessity and sufficiency in subplate neuron-
mediated circuit assembly, we discovered that the chromatin remodeler Arid1a is essential for the wiring
functions of subplate neurons. Human ARID1A mutations are a cause of Coffin-Siris syndrome, a developmental
disorder characterized by callosal agenesis. We found that cortical Arid1a deletion led to callosal agenesis and
thalamocortical axon misrouting reminiscent of subplate ablation. These miswiring phenotypes coincided with
disruptions in the transcriptional identity of subplate neurons, and deficits in subplate neuron wiring functions,
including subplate-thalamocortical axon “handshake” and extracellular matrix. Thus, in Arid1a, we identified a
multifunctional regulator of subplate neuron-dependent axon guidance functions – a key discovery that opens
doors to molecular and mechanistic studies on subplate neurons. In preliminary studies using the same genetic
strategy, we further identified an additional regulator of subplate-mediated circuit wiring in the transcription factor
Sox5. Mutations in human SOX5 cause Lamb-Shaffer syndrome, a neurodevelopmental disorder characterized
by intellectual disability. Here, we will leverage the exceptional opportunities that Arid1a and Sox5 provide to
study subplate neurons. We will use our expertise in molecular genetics, circuit neurobiology, genomics, and
chromatin biology, to identify the transcriptomic and genomic targets of Arid1a and Sox5 (Aims 1 and 2) and
gain a functional understanding of candidate genes in subplate neuron-dependent axon guidance (Aim 3). A key
implication of our work is that deficits in subplate neurons may be an underappreciated contributor to neural
circuit miswiring in neurodevelopmental disorders, including those associated with chromatin dysregulation.
Successful completion of the proposed study on subplate neurons will thus illuminate fundamental mechanisms
of circuit development, and the potential consequences of subplate dysfunction in developmental brain disorders.

Public health relevance
PROJECT NARRATIVE The mammalian cerebral cortex is the center of remarkable cognitive, perceptive, and motor capabilities, the execution of which depends on the correct assembly of circuit connectivity during development. Miswiring of cortical circuitry can contribute to disorders of brain development. In this study, we seek to understand the roles of subplate neurons in orchestrating the formation of cortical circuits, and the potential contribution of subplate neuron dysfunction to neurodevelopmental disorders.